Training Program in Genomic Medicine

ABSTRACT
The T32 Genomic Medicine Training Program at the University of Utah prepares pre- and postdoctoral trainees
to be well-rounded, collaborative leaders in genomic medicine. Building on a strong institutional record of training
in genomics and the unique training environment of the multidisciplinary Center for Genomic Medicine at
University of Utah Health, the two-year basic research track training program consists of coursework, a mentored
research experience, experiential learning activities, extensive interactions with a broad community of genomic
medicine researchers, and career development activities. Core courses cover the ethical, legal and social
implications of genomic medicine, grant writing techniques, and practical skills for applying computational tools
for disease-gene discovery and patient genome interpretation. A mentored genomic medicine research
experience in a team science environment is the heart of the training program. Each trainee will have a
multidisciplinary mentoring committee, drawn from a mentor pool of 34 MD and PhD genomic medicine
researchers. This highly collaborative mentor community possesses expertise in the many disciplines that
underpin genomic medicine, including human genetics, bioinformatics, epidemiology, statistics, molecular
diagnostics, and pharmacogenomics. Trainees will benefit from several unique resources and collaborators in
the Center for Genomic Medicine: the Utah Genome Project, an independently funded research project in which
thousands of members of large Utah disease pedigrees are undergoing whole-genome sequencing; the Utah
Center for Genetic Discovery, the University’s computational genomics engine and hub for development of
software tools and algorithms for genome interpretation; ARUP Laboratories, the University’s national reference
lab and a leader in developing genomics-based clinical diagnostic tests; the Penelope Program, the University’s
clinic for rare and undiagnosed disease, which is part of the Undiagnosed Disease Network; the Utah NeoSeq
Project, an initiative to bring rapid whole genome sequencing to the neonatal intensive care unit; and the
Huntsman Cancer Institute, a National Cancer Institute Designated Comprehensive Cancer Center and home to
extensive cancer genomics and precision oncology projects. Each of these will provide immersion opportunities
in genomic medicine. The overall goals of the T32 program are: to teach trainees to apply cutting-edge
bioinformatics and computational tools to analyze genomic datasets; to work productively with interdisciplinary
teams in the clinical application of genomic data; to protect and communicate effectively with research
participants; and to advance an independent research career in genomic medicine. At steady state, the training
program will include five predoctoral and four postdoctoral trainees each year. In the past funding period, nine
postdoctoral trainees were appointed, advancing their careers in genomic medicine. Trainee outcomes data are
tracked, and best practices and course materials will be disseminated across the NHGRI training network.

Public health relevance
NARRATIVE The increasing affordability of genome sequencing has created new opportunities to personalize health care. To maximize the clinical impact of genomic information, we must train a workforce of physicians and scientists to interpret and manage genomic data, to work within teams of researchers from different disciplines, and to communicate genomic information effectively and responsibly to patients. Armed with this training, a new generation of scientists will develop and apply precision diagnostics and therapies to provide truly personalized health care.